Harnessing Molecular Networks of Resilience for Therapeutic Discoveries in AD

Although protection from and resilience to Alzheimer's disease (AD) constitute a fundamental aspect to
understanding AD pathophysiology, this is a relatively understudied area and the molecular basis of resilience
to AD is largely unknown. This is a critical knowledge gap, as uncovering biological pathways of resilience
could lead to the discovery of novel therapeutic or prophylactic drug targets in AD. It is clear that there are
individuals who may be protected from developing AD pathology, despite advanced age and having highly
penetrant genetic risk factors for AD, such as APOE ε4 allele. Additionally, there are people with cognitive
resilience who remain free of cognitive decline despite having pathologic or biomarker changes of AD. Current
therapeutic discovery efforts in AD are largely focused on uncovering the biological pathways that are
perturbed in this condition, the key molecules in these pathways, and identification of therapeutic compounds
to stop and/or reverse these perturbations. These efforts are based on the hypothesis that concerted
perturbations of molecular networks that serve key biological functions underlie the pathophysiology of many
common, complex diseases including AD. While it is critically important to discover perturbed molecular
networks in AD, this is only one side of the coin. We postulate that application of network biology approaches
to investigate individuals who are protected from and resilient to AD can uncover novel biological pathways
that underlie resilience to AD. In addition to revealing novel resilience pathways, study of resilient individuals is
also critical for the validation of perturbed disease networks, as we expect some of the susceptibility and
resilience networks to overlap but have opposite direction of effect. Such validation efforts are essential for the
translation of these discoveries to viable drug targets. In this proposal, we plan to study individuals who are
protected from and resilient to AD by leveraging samples from autopsied and living human cohorts, to utilize
existing and generate new molecular data, including RNA sequence (RNAseq) and whole genome sequence
(WGS), and to apply analytic approaches to identify resilience networks. We will utilize single-nucleus RNAseq
(snRNAseq) to identify cell-specific molecular changes of resilience in brain and validate these using iPSC-
based models. To translate this knowledge to therapeutic targets, we will apply novel pharmacogenomics
tools. Our proposal is responsive to the RFA-AG-18-029 and aims to: 1) Identify molecular targets of resilience
to development and propagation of AD pathology in an autopsy cohort enriched for older controls; 2) Identify
molecular targets of cognitive resilience in the presence of AD biomarkers in a longitudinally assessed older
cohort enriched for clinically normal individuals with positive amyloid PET and APOE ε34 or ε44 genotypes; 3)
Validate cell-specific molecular changes in iPSC-based models; 4) Decipher druggable targets of AD resilience
and potential therapeutic compounds using systems-based pharmacogenomics tools. We will integrate our
findings with those from AMP-AD, M2OVE-AD, ADNI and ADSP and share all generated data and tools.

Public health relevance
Although protection from and resilience to Alzheimer's disease (AD) constitute a fundamental aspect to understanding AD pathophysiology, this is a relatively understudied area and the molecular basis of resilience to AD is largely unknown. In this proposal, we aim to fill this knowledge gap and plan to study cohorts resilient to AD pathology and cognitive decline by leveraging existing and generating novel molecular data to identify biological pathways that confer resilience to AD, to validate these pathways in experimental model systems and to identify potential AD therapeutics that promote resilience. We expect our proposal to uncover networks and molecules of resilience and to validate findings of other large-scale efforts to translate these discoveries to viable candidate drugs for AD.